Core A: Administrative Core

The Administrative Core is responsible for overall planning of the Center, providing a direction and focus that are consistent with the mission of the NIEHS, coordination of all Center components, evaluation of progress, allocation of budgets and oversight of expenditures, and day-to-day operations. The elements of this Core are its Personnel and Programs. These are depicted in Table 1 and described below. TABLE 1: Elements of the Administrative Core PERSONNEL • Director • Deputy Director • Center Administrator • Administrative Staff • Coordinator, Shared Instruments and Oversight • Internal Policy Committee (IPC) • External Advisory Committee (EAC) PROGRAMS • Pilot Project Program • Director's Fund • Shared Instruments and Oversight • Center Seminar Series • Monthly Center Meetings • Annual Retreat and Conferences • Web Site